Molecular mechanisms and functions underlying the role of Fto in mu opioid actions

Project Summary/Abstract
Mu opioids, such morphine and fentanyl, remain in the mainstream for moderate and severe pain management.
However, they also produce many side-effects such as tolerance and addiction, leading to the development of
opioid use disorder, a main cause of the opioid epidemic and climbing opioid overdose death. Mechanisms
underlying mu opioid actions, particularly their side-effects such as tolerance and reward, are extremely complex
and involve multiple distinct systems or diverse signaling pathway. Fat mass and obesity-associated protein
(FTO) was initially identified as a demethylase of N6-methyladenosine (m6A), a modified nucleotide in mRNA.
Later, it was found that Fto exhibits significantly higher catalytic activity in demethylation of N6,2'-O-
dimethyladenosine (m6Am) compared to m6A. Accumulating evidence suggests that FTO influences gene
expression by modulating mRNA stability, alternative splicing, translation, and epigenetic modulation. Notably,
FTO has emerged as an important molecular player in various neuronal functions, and neuropsychiatric
disorders. Recently, we investigated the involvement of FTO in mu opioid actions, specifically tolerance and
reward in mice. Our preliminary data demonstrated that Fto depletion or inhibition significantly reduced morphine
and fentanyl tolerance and morphine reward measured by conditioned place preference (CPP). Furthermore,
depleting Fto in the nucleus accumbens shell (NAcSh) by microinjecting AAV-Cre in Ftofl/fl mice or the dorsal root
ganglion (DRG) by inducing Cre expression in the DRG by tamoxifen in Ftofl/fl:Advillin-CreER2 mice led to
attenuation of morphine CPP and tolerance, respectively. Additionally, we performed a preliminary transcriptome
study using the NAcSh of Fto-NAcSh-depleted mice, which revealed alterations in gene expression and
alternative splicing. Collectively, these strongly support an overarching hypothesis that Fto contributes to mu
opioid reward and tolerance in the NAcSh and DRG, respectively, through distinct molecular mechanisms. FTO
inhibition or modulation of a key molecule or pathway downstream of FTO in a specific region may therefore
represent a new approach for preserving mu opioid analgesia while mitigating specific unwanted side effects. To
test this hypothesis, we propose the following three specific aims. Aim 1. Determine the role of Fto in the NAcSh
and DRG on mu opioid tolerance and reward by CPP and intravenous self-administration. Aim 2. Determine if
the role of Fto in the NAcSh and DRG on mu opioid reward and tolerance is mediated by increased m6Am or
m6A by using double-floxed mouse models, Ftofl/flPcif1fl/fl and Ftofl/flMettl3fl/fl. Aim 3. Investigate molecular
mechanisms underlying the role of Fto in the NAcSh and DRG on mu opioid reward and tolerance using several
cutting-edge approaches, including m6Am/m6A mapping, miCLIP, SLAM-seq, GLORI, ribosome profiling and
RNA-seq. The proposed studies promise to provide new insights into in vivo molecular mechanisms in mu opioid
action regarding RNA methylation and identify new targets downstream of FTO, which may have therapeutic
potentials for developing a novel strategy to reduce mu opioid tolerance and reward in pain management.

Public health relevance
Project Narrative Mu opioids such morphine and fentanyl are potent in relieving pain, but they produce many side-effects such as tolerance and addiction, leading to the worldwide opioid epidemic and climbing opioid overdose death. The proposed studies aim to investigate novel molecular mechanisms and functions of mu opioid tolerance and reward that are mediated through fat mass and obesity-associated protein (FTO), a mRNA demethylase.